DOSE RATE EFFECTS FOR MUTATION BY IONIZING RADIATION IN HUMAN LYMPHOBLASTS

The goal of this project is to check the cell cycle distribution of cell lines with different repair capacities following different low dose-rate irradiations in order to determine if differences in cell cycle distribution can account for the low dose-rate effects observed. Experiments now require more detailed cell cycle progression information and are using BrdU incorporation protocols with analysis on the multi laser system.